BIOLOGICAL VARIATION OF ACTIVITY AND METABOLIC MEASUREMENTS IN LBW INFANTS

This study will test the hypotheses that activity correlates with mean energy expenditure (MEE), oxygen consumption (VO2) and carbon dioxide production (VCO2) and that activity correlates with behavioral state.